Systems Science Informed Multilevel Theoretical Model of Cardiovascular Health in Native Hawaiians

PROJECT SUMMARY
The purpose of this K01 application is to support the research and career development of Dr. Claire Townsend
Ing in establishing herself as an independent investigator engaging community and using system science
theory and methods to examine and address multilevel determinants of cardiovascular disease. Native
Hawaiians bear a disproportionate burden of hypertension and cardiovascular disease. Culturally tailored
interventions guided by psychosocial theories are effective at producing individual behavior change to improve
health outcomes, but multilevel interventions are needed to expand and sustain these improvements. Multilevel
interventions are particularly relevant for hypertension prevention as blood pressure is influenced by risk and
protective factors at individual, family, community, societal, and environmental levels. However, research
examining these factors' complex interactions and processes is lacking in Native Hawaiians. Such information
is critical to developing a multilevel theoretical model of Native Hawaiian cardiovascular health to guide the
design of culturally relevant, multi-level interventions for this understudied group. Dr. Ing will build on her
experience in community-based participatory and translational research to achieve four short-term career
objectives; to improve her knowledge and skill in 1) the scientifically rigorous examination of multilevel
determinants of cardiovascular health, 2) systems science theory and methods to include group-based model
building and community-based system dynamics, 3) hypertension and CVD prevention, and 4) Native
Hawaiian community engagement. The proposed research will build on a partnership with a USDA-funded
study (Children's Healthy Living Center of Excellence) that includes 6 Native Hawaiian communities. Its 2019
reassessment will include sociodemographic, psychosocial, behavioral, household, and community factors.
Through leveraging this partnership, Dr. Ing will recruit 240 adults for additional data collection on blood
pressure, height, weight, and behavioral and psychosocial factors (e.g., diet, physical activity, discrimination).
Using these data, she will examine the relationships between individual, household, and community factors
and blood pressure. Additionally, she will engage community leaders in 6 focus group workshops (n=48) to
create causal structures of perceived links between multilevel factors and HTN. She will then synthesize the
qualitative data and causal structures to create a causal loop diagram. This causal loop diagram will serve as a
novel theoretical model of cardiovascular health in Native Hawaiians. The specific aims are: 1) to estimate the
associations between behavioral (physical activity, diet, alcohol consumption, tobacco use), biological (BMI),
psychosocial (acculturation, discrimination), household (size, composition, food scarcity, use of food
assistance), and community (walkability, food environment) factors and blood pressure in 240 adult Native
Hawaiians, and 2) engage community leaders via focus group workshops to create a causal loop diagram
depicting multilevel determinants of cardiovascular health in Native Hawaiian communities.

Public health relevance
PROJECT NARRATIVE This research will collect data on multilevel determinants of blood pressure in Native Hawaiians and engage Native Hawaiian community leaders in the creation of a novel, multilevel theoretical model of cardiovascular health. This improved understanding of the structure and processes of multilevel determinants of cardiovascular health is critical to the creation of culturally relevant and effective multilevel interventions for Native Hawaiians and other understudied populations. These interventions can decrease disparities in cardiovascular disease and improve cardiovascular health.